Metabolomics Core

ABSTRACT
In the last two decades, the field of metabolomics has evolved tremendously due to significant advances in
analytical technology and informatics. However, these advances have not efficiently been used to augment our
understanding of bacterial physiology or host-pathogen interactions. The proposed Metabolomics Core will
address this deficiency by assisting the various projects in this PPG that deal with the physiology of
Staphylococcus aureus and its interaction with the host. Specifically, the Metabolomics Core will standardize
research methodology involved with the extraction of intracellular and excreted metabolites, establish a firm
rationale for the interpretation of affected metabolic pathways based on long-standing biochemical principles,
design advanced protocols for the detection of unique cellular metabolites and utilize tracer metabolites (e.g.
C13- labelled metabolites) to investigate specific metabolic pathways. These aims will be achieved following the
acquisition of the state-of-the-art Q Exactive Gas Chromatography (GC-MS/MS) mass spectrometer which
enables both targeted and untargeted analyses due to its High-Resolution Accurate Mass (HRAM) Orbitrap
technology. The GC-platform will not only complement existing Liquid Chromatography-Mass Spectrometry (LC-
MS/MS) based methods currently being utilized by the core but will also uniquely be useful for studies aimed at
determining carbon flux measurements through metabolic pathways. We anticipate that the Metabolomics Core
will be indispensable for the successful outcome of projects associated with this PPG and further, will be a critical
resource for the broader staphylococcal research community.